Dynamic Changes in Chloride Homeostasis Coordinates Midbrain Inhibitory Network Activity during Reward Learning

ABSTRACT
The mechanisms underlying how rewards are learned, and how they translate into behavior have been
a subject of interest to researchers and scientists since Pavlov’s classical conditioning experiments in the
1890s. Recently, Gamma Amino Butyric Acid (GABA) neurons in the Ventral Tegmental Area (VTA) have
emerged as key modulators of reward learning, and potential therapeutic targets for addressing addiction,
depression, and other neuropsychiatric disorders. Previous studies have shown that GABA neurons in the VTA
undergo a form of experience-dependent plasticity that involves the downregulation of the anion transporter,
KCC2. This reduction of KCC2 levels has been found to increase the excitability of GABA neurons by
decreasing the efficacy of GABAA receptor function. In the context of drugs of abuse and aversive stimuli, this
mechanism has been studied in great detail. For instance, exposure to nicotine and stress has shown to
induce KCC2 downregulation in the VTA, which in turn, enhances the formation of reward-seeking behaviors.
The impact of this mechanism on specific reward-related pathways and its contribution to naturalistic reward
learning, however, remains unknown.
To investigate this matter, I propose to characterize the expression of KCC2 throughout the course of
cue-reward associative learning, and determine whether its downregulation is limited to a specific circuit (Aim
1). My preliminary evidence demonstrates that KCC2 downregulation shifts lateral VTA GABA neurons towards
excitability at critical time points during reward learning. More precisely, KCC2 downregulation transiently
impacts inhibitory inputs to lateral projecting VTA DA neurons, which are known to play a significant role in
reward learning. Subsequently, I seek to understand how a collection of inhibitory neurons undergoing this form
of synaptic plasticity can influence the lateral VTA at the network level (Aim 2). To this end, I will combine
multi-unit tetrode recordings with pharmacological and genetic approaches to examine neural network activity
during reward learning. My preliminary data shows that KCC2-mediated plasticity drives increased
synchronized activity between VTA GABA neurons.
This multidisciplinary proposal will investigate whether circuit-specific modifications in KCC2 serve as
an innate mechanism during reward learning that allows the brain to establish enduring associations between
contextual cues and appetitive stimuli. The findings from this proposal will guide new therapeutic avenues for
neuropsychiatric disorders with deficits in reward learning.

Public health relevance
PROJECT NARRATIVE The research proposed under this F31 fellowship will assess the role of KCC2-mediated synaptic plasticity in the VTA during naturalistic reward learning and will characterize the circuitry involved in this process. This will allow for the establishment of KCC2 modulation as a novel form of synaptic plasticity during reward learning and will demonstrate the potential of KCC2 as a target for intervention to treat neuropsychiatric disorders that are characterized by aberrant reward learning such as obsessive compulsive disorder and schizophrenia, among many others.